Neoadjuvant immunotherapy approaches to early stage melanoma

Project Summary – Project 3
There is an unmet need to improve the survival of patients with high-risk Stage II melanoma. Currently, the
treatment for Stage II melanoma is surveillance despite unacceptably high recurrence and mortality rates
observed with surgery alone. The sentinel lymph node (SLN) is the first lymph node drained by a primary tumor
and is not only a target for metastasizing cancer cells but also an immunological sensor of tumor antigens
released by primary cutaneous melanoma. Our preliminary data in a draining lymph node (LN) metastasis model
shows striking increases in myeloid cell populations prior to and during melanoma metastasis to the LN. We
propose that these changes in the LN may compromise its ability to act (i) as a gatekeeper to prevent melanoma
spread via the lymphatics and (ii) as an instructor of antigen-specific T cell immunity capable of controlling local
disease and intervening on hematogenous spread. Thus, our overall hypothesis is that the capacity of the
SLN to protect against locoregional and distant melanoma spread is dependent on its immune health,
which is pliable and determined by the immunostimulatory capacity of lymph node-resident myeloid
cells. In Aim 1, Drs. Karakousis (Clinical co-Project Leader (PL)) and Schuchter (co-Investigator (I)) will conduct
an investigator-initiated Phase II clinical trial of neoadjuvant pembrolizumab in clinical Stage IIB/C melanoma.
Using primary tumors and sentinel LNs (SLN) from both this clinical trial and stage-matched historical cohorts,
we will determine the effects of immunotherapy on the immunophenotype and anti-metastatic capacity of the
SLN. We will use a combination of unbiased global profiling strategies pioneered by Dr. Wherry (co-I) and
hypothesis-driven approaches guided by our discoveries into the role of macrophages in preparing the metastatic
niche (Beatty, Applied co-PL) to determine therapy-associated changes in SLN-positive and -negative patients.
Studies in syngeneic models will then inform the role of myeloid cell subsets in directing changes in LN biology
triggered by melanoma development and their impact on anti-PD1 therapy. Aim 2 will test the hypothesis that
the immunostimulatory capacity of lymph node dendritic cells determines the likelihood of response to anti-PD1
therapy. Under the leadership of co-PLs Drs. Herlyn and Beatty , we will use multiplex tissue- and cell-based
assays to analyze samples collected from our Phase II trial and stage-matched historical controls with the goal
to define T cell interactions with myeloid cells, including dendritic cells, and their impact on treatment response
and clinical outcomes. In addition, we will determine if clinically-available TLR agonists can enhance the
immunostimulatory capacity of the draining LN and in doing so, improve the efficacy of anti-PD-1 therapy using
humanized mice challenged with patient-derived xenografts which model early stage melanoma with high fidelity.
Impact: We anticipate neoadjuvant immunotherapy will substantially reduce SLN positivity rates warranting future
randomized studies designed to change clinical practice. We expect to identify the SLN as an important
determinant of melanoma pathogenesis and clinical outcomes to immunotherapy.

Public health relevance
Project Narrative – Project 3 Patients with high-risk Stage II melanoma have an unacceptably high mortality rate with surgical treatment alone. In this study, we will test the hypothesis that neoadjuvant immunotherapy can be used to reshape the tumor microenvironment in the draining lymph node to limit or eradicate the disseminated malignant cells, thus, increasing cure rates. We will determine the clinical and immunological impact of neoadjuvant anti-PD1 antibody therapy in high risk clinical Stage II melanoma and identify new rational combinations for high-risk Stage II melanoma.